The Primate Corticospinal Connectome and Transcriptome - Supplement

Abstract
We recently published a report demonstrating that, remarkably, adult corticospinal neurons in the mouse revert
to an embryonic transcriptional state after spinal cord injury (SCI) (Poplawski et al. Nature 2020). This state
persists for two weeks, then reverts to an adult transcriptional state in which neurons are more refractory to
regenerative therapies. This grant seeks to determine whether embryonic reversion of corticospinal neurons also
occurs in primate corticospinal motor neurons after SCI, and if so, how long this state endures. This is critical
information for planning human clinical trials because efforts to repair the injured spinal cord are most likely to
be effective in the time period that corticospinal are in an embryonic state and most able to regenerate and
respond to pro-growth therapies.
Our results to date have shown that embryonic reversion of primate corticospinal neurons indeed appears to
occur. We sampled time points of 3, 10 and 20 days after SCI. We find that embryonic reversion is present at
Day 10 and is nearly gone by Day 20. We now seek to add an additional time point, 15 days, to this study. If
embryonic reversion is still present 15 days after SCI, one could extend the duration of potential patient
recruitment into clinical trials, representing an important improvement in increase the number of people eligible
for pro-regenerative trials. This information is important not only for our stem cell program that we aim to clinically
translate, but for any pro-regenerative treatment trial in humans.
We will use techniques that have been successfully employed in this grant to date. We will perform RNAseq of
corticospinal neurons in rhesus monkeys using retro-AAV vectors expressing HA- and FLAG- tagged
polyribosomes. We then use translational Ribosomal Affinity Purification (TRAP) to obtain and sequence
corticospinal-specific mRNA species. We will add to our current timeline a 15 days post injury group (n= 3) and
one more monkey (n=1) to our 10 day post top strengthen statistical power and enable batch correction.

Public health relevance
Narrative This is a request for an administrative supplement to our original grant. These funds will extend Aim 1 of the original study that identified transcriptomic embryonic reversion of corticospinal motor neurons after focal spinal cord lesions. In studies performed successfully to date, we have identified an initial time window for this reversion, and now seek to understand with more precision when the pro-growth window closes; this will critically inform human clinical trials into spinal cord repair.